Proof of Concept Trial of a Mindful Walking Intervention for Black Women with Hypertension

ABSTRACT
Hypertension disproportionately affects Black women and is a key risk factor for cardiovascular
disease, a leading cause of death. As many as 39.9% of Black women have hypertension compared to
Asian women (21.9%), Hispanic women (28%), and White women (25.6%). Among women with
hypertension, Black women are 2.3 times more likely than white women to have uncontrolled blood
pressure (BP). Physical activity can reduce hypertension risk and incidence, but rates are low among
Black women. The vast majority of Black women (83.3%), are not meeting the national guidelines for
physical activity. Stress is known as a key risk factor for hypertension as well as a major barrier to
physical activity among Black women.
To address hypertension and physical activity disparities among Black women, we propose a
technology-delivered mindful walking intervention to reduce stress, increase PA, and ultimately reduce
blood pressure in Black women with hypertension. We will leverage culturally-relevant frameworks on
stress among Black women such as the Superwoman Schema to understand the role of stress on health
outcomes in Black women to tailor the intervention. We will conduct focus groups with N=30 Black
women with hypertension who are insufficiently active to gather insights about 1) barriers and facilitators
to engaging in physical activity, 2) views of the Superwoman Schema, and 3) perspectives on a remotely
delivered mindful walking intervention, including the modality, goals, walking pad, and content. Using
the ORBIT model for intervention design, we will then develop and test the intervention in a 1-arm proof
of concept study. Findings will inform the development of the intervention in preparation for an efficacy
trial. We will enroll N=30 Black women into a 12-week Facebook-delivered mindful walking
intervention. Feasibility outcomes will include recruitment, retention, engagement, and acceptability.
Following this proof-of-concept test, we will conduct post intervention focus groups with participants to
further refine the intervention.
Building on Dr. Kalinowski’s prior pilot work on mindfulness and hypertension in Black women,
this study will provide her with training in designing, developing, and implementing technology-delivered
physical activity interventions to reduce CVD risk among Black women. This project contributes to Dr.
Kalinowski’s long-term goal of designing technology-delivered physical activity interventions that can be
leveraged to reduce CVD burden among Black women. Dr. Kalinowski has access to a rich research
environment at the University of Connecticut along with expert mentors who are dedicated to her training
and long-term development as an independent researcher.

Public health relevance
PUBLIC HEALTH RELEVANCE High blood pressure is estimated to cost the United States 131 to 198 billion dollars annually. High blood pressure is one of the most influential risk factors for cardiovascular disease, which is a leading cause of death in the United States. Despite increased knowledge, awareness and uptake in hypertensive medications, racial/ethnic disparities in hypertension persist. Physical activity (PA) is a key, modifiable lifestyle modification that can improve BP outcomes and reduce hypertension risk. Yet, uptake of PA remains low among Black women. We propose to test the proof-of-concept of a technology-delivered mindful walking intervention among Black women with hypertension to increase PA and reduce BP.